Role of cytokines and APOL-1 in the pathogenesis of childhood HIV associated nephrology

SUMMARY
HIV-associated nephropathy (HIVAN) is a renal disease caused by the infection of renal epithelial cells (REc)
that is seen more frequently in people of African ancestry who carry two APOL1 risk alleles (APOL1-RA)
named G1 or G2. The study of HIVAN provides a unique opportunity to define how contacts between HIV+
inflammatory cells and REc may contribute to establish a kidney HIV-1 reservoir, and to determine how APOL1
interact with HIV-1 to precipitate HIVAN in people of African ancestry. In the first cycle of the grant, we have
demonstrated that transmembrane TNF-α (tm-TNF-α) facilitates the infection of podocytes and REc cultured
from children with HIVAN, and increases the expression of APOL1 in synergy with HIV-1. We also found that
tm-TNF-α and APO1 interact to modulate common pathways involved in endocytosis, HIV-1 trafficking, and
degradation in REc. Thus, we hypothesize that tm-TNF-α plays a critical role in the pathogenesis of childhood
HIVAN by facilitating the infection of REc through cell-to-cell contacts with mononuclear cells, and by
increasing the activity of APOL1-RA in these cells. In HIV+ podocytes, these changes tip their homeostatic
balance, impairing key endocytic and autophagic pathways that affect their structure, function, and survival. In
turn, these events precipitate HIVAN in children and adults. This hypothesis will be tested in three aims. In
aim 1, we will determine how tm-TNF-α modulates the transfer of HIV-1 from mononuclear cells to REc
cultured from HIV+ children, and elucidate the mechanisms involved. In aim 2 we will define how tm-TNF−α
and APOL1-RA interact in vivo to modulate relevant endocytic and autophagy pathways that are essential for
the normal function of Drosophila nephrocytes (the fly equivalent of human podocytes) and for the traffic of
HIV-1 particles in podocytes. In aim 3, we will determine how APOL1-RA modulate the infection of podocytes
cultured from HIV+ children, and define the risk of children carrying two APOL1 RA to develop HIVAN. In
summary, these experiments will elucidate how REc are infected with HIV-1, and interact with renal infiltrating
inflammatory cells and the APOL1-RA to establish a renal HIV-reservoir and induce chronic kidney diseases.

Public health relevance
HIV+ children and young adults who carry two copies of the risk variants of a gene named APOL1 are at higher risk of developing chronic kidney failure, however, the mechanism is poorly understood. This proposal will close a critical gap in our knowledge to understand how the inflammatory cytokine TNF-α, interacts with HIV-1 and APOL1 to infect renal epithelial cells, establish a kidney reservoir, and induce chronic kidney disease in HIV+ children of African ancestry.